The role of GLP-1 and CCK in the pancreatic islet to promote beta-cell survival

Reduced β-cell mass and increased β-cell apoptosis are key to the pathophysiology of both type 1 and type 2 diabetes. Therefore, identifying factors that can protect from β-cell apoptosis will meet a critical thera- peutic need in the prevention and treatment of diabetes. Glucagon-like peptide-1 (GLP-1) and cholecystokinin (CCK) are peptide hormones normally produced in the intestine with beneficial effects on β-cell mass and func- tion. Both GLP-1 and CCK are produced within the pancreatic islet under conditions of islet stress. GLP-1 based therapies are in widespread use for the treatment of type 2 diabetes, and there is substantial evidence in cell lines and rodent models that GLP-1 can protect from β-cell apoptosis. Similarly, we have shown that CCK is necessary and sufficient to protect from β-cell apoptosis in mouse models. While CCK has been widely studied in exocrine pancreatic cells, there is limited information about the role of CCK in the β-cell. We propose that the production of these hormones in the islet represents a compensatory physiologic mechanism to pro- mote β-cell survival. The long-term goal is to identify novel pathways critical in the preservation of β-cell mass. The overall objective of this application is to determine the regulation of locally produced GLP-1 and CCK and their role in protection from β-cell apoptosis. The central hypothesis is that an intra-islet signaling network ex- ists, whereby GLP-1 produced in the α-cell and CCK produced in the β-cell are co-regulated and work together to promote β-cell survival. To achieve the objective, three Specific Aims are proposed. In Aim 1, we will deter- mine how GLP-1 and CCK production are regulated in the pancreatic islet. Preliminary evidence support the hypothesis that CCK and GLP-1 signal in a paracrine manner within the islet to co-regulate one another. We will use transgenic overexpression of β-cell CCK and receptor knockout mouse models to clarify how these hormones regulate one another in the islet. In Aim 2, we will identify the mechanism of CCK-mediated protec- tion from cytokine-induced apoptosis. We will use receptor antagonists and knockouts to determine which CCK receptor regulates β-cell survival and we will determine the intracellular signaling pathways activated by CCK in the β-cell. In Aim 3, we will determine if GLP-1 and CCK can synergistically and interdependently protect human islets from apoptosis. We have intriguing evidence that the role of GLP-1 in β-cell survival is dependent on CCK receptor signaling in a cell line. This suggests the innovative concept that the impact of GLP-1 on the β-cell relies on its ability to stimulate CCK. As human islets have very different characteristics than mouse islet, examining the role of GLP-1 and CCK specifically in human islets is of critical importance to translation of our findings to diabetes therapies. These studies will contribute to our fundamental understanding of this novel in- tra-islet hormonal regulatory pathway and the mechanisms whereby GLP-1 and CCK promote β-cell survival. This contribution is significant as it will advance knowledge of both adaptive and therapeutic mechanisms of β- cell survival, allowing development of targeted therapies with maximal efficacy and minimal side effects.

Public health relevance
Project Narrative Diabetes affects over 29 million people in the United States, making it a serious public health challenge. A key part of the pathogenesis of diabetes is the loss of function -cells, partly through increased -cell apoptosis. This project is relevant to the mission of the NIH in combating diabetes by providing fundamental knowledge about novel pathways to protect -cells from death.